Research Training in Childhood Stress, Trauma, and Resilience

PROJECT SUMMAY / ABSTRACT
There is increasing evidence for a profound and persistent impact of childhood stress and trauma on adverse
behavioral and physical health outcomes across the lifespan. However, progress toward elucidating
mechanisms of risk and novel prevention and intervention efforts to promote resilience is limited by the small
number of investigators trained to conduct translational, developmentally-informed research focused on
childhood stress, trauma, and resilience. The proposed postdoctoral research training in childhood Stress,
Trauma, and Resilience (STAR T32) takes a broad approach to stress, adversity and traumas experienced by
children and families and their impact on biobehavioral mechanisms and health outcomes across development.
The STAR T32 is an intensive research fellowship designed to prepare PhD and MD postdoctoral fellows to
conduct cutting-edge, translational, developmentally-informed research on childhood stress, trauma and
resilience, and would be the only NICHD-funded training program within Brown Medical School. The T32 will
enroll 12 postdoctoral fellows (2-3 per year) for two-year terms over the five-year award. Fellows will have a
PhD in a behavioral health-related field (psychology, public health/epidemiology, neuroscience) or an MD in a
related specialty (psychiatry, pediatrics, emergency medicine). The program embraces an apprenticeship
model where fellows work closely with one of a broad base of exceptional faculty mentors conducting
innovative, NIH-funded, translational research in STAR-related areas often involving diverse, underserved and
disadvantaged populations. Mentors include PhDs and MDs with a breadth of research interests and
transdisciplinary expertise from psychology and psychiatry to public health, pediatrics and emergency
medicine. Fellows will also obtain focused didactic training covering four critical STAR domains: (a) exposures
and trauma, (b) pathways and mechanisms, (c) health behaviors and outcomes, and (d) interventions and
community partnerships to promote resilience. They will also obtain rigorous foundational training in research
design and statistics, grant-writing, responsible conduct of research, professional development, and cutting-
edge methodological approaches. The program leverages a unique and long-standing training infrastructure
and culture of collaboration within The Miriam Hospital and the Brown Department of Psychiatry and Human
Behavior, allowing for a large base of trainee colleagues, faculty experts, didactics and support. More than
90% of past fellows with STAR mentors have gone on to successful, research-intensive careers, with
numerous publications obtained during postdoctoral fellowship. The T32 will also enhance and leverage
Brown’s track record of recruitment of highly accomplished trainee candidates, with plans in place for focused
recruitment of racially/ethnically and socio-economically diverse fellows. The STAR T32 fits with the mission of
the NICHD Pediatric Trauma and Critical Illness Branch, including a focus on collaborative and translational
research to promote discoveries, and preventing, treating, and reducing all forms of childhood trauma.

Public health relevance
PROJECT NARRATIVE Childhood stress and trauma are pernicious public health problems linked to increased risk for an enormous array of behavioral and psychiatric disorders and chronic medical conditions across the lifespan. However, progress toward prevention and intervention to reduce the toll of childhood stress and trauma and promote resilience is limited by the small number of researchers trained to conduct translational, developmentally- informed research focused on mechanisms and health consequences of childhood stress and trauma. Training a cohort of diverse researchers to conduct cutting-edge, rigorous research in childhood stress, trauma and resilience is critical to improve childhood health and prevent disease.